Mechanisms of intracellular transport and processing of neuropeptides

Project Summary/Abstract
A major form of communication between cells, including the nervous system, is the release of small, chemical
factors, like neuropeptides (NPs) and hormones. These molecules are used for communication both on a local
level and at a systemic level, where they regulate and mediate developmental, physiological, and behavioral
events. Molecules like neuropeptides are packaged in specialized cellular compartments called Dense Core
Vesicles (DCVs). Despite decades of research, little is known about the in vivo biology of DCVs, from the
mechanism governing their sorting into appropriate cargo, to how they are properly processed into mature
bioactive peptides, to how they undergo release from cells. There are hundreds of different NPs in the human
brain, most with completely unique cellular and physiological impacts. Some of society’s most severe and
debilitating diseases and conditions including neurodegenerative and neurological disorders result from
abnormalities in the packaging or release of these molecules. The long-term objective of this research seeks to
understand the molecular machinery regulating the synthesis, sorting, trafficking, and release of NPs from DCVs.
To initially investigate this process, we created 14 different transgenically tagged NP Drosophila fly lines to
directly visualize the intracellular localization, sorting, trafficking, and release of neuropeptides from neurons in
an in vivo system. We initially uncovered evidence that individual NPs are sorted on an mRNA level to regulate
the identity of each DCV. In Aim 1 we propose to solidify this result by creating several new transgenic fly lines
using the most novel and modern cloning approaches like tissue specific CRISPR and newly created fluorescent
tags like mScarlett3. This approach will tag endogenous NPs within the genome and facilitate a real-time
examination of their sorting, trafficking, and release mechanisms when combined with out high-resolution-ultra
fast fluorescence microscopy. Aims 1 and 2 use genetic, biomolecular, cloning, electrophysiological and
pharmacological approaches combined with confocal and live imaging in an in vivo system to define the proteins
and processes involved in NP sorting in the trans-Golgi network. We predict that the complex of proteins found
on each DCV is unique to the NP within, and this NP-dependent protein complex defines the machinery used for
downstream trafficking and release. We have identified a subset of proteins known to regulate trafficking and
release (e.x. synaptotagmin) and will genetically alter the structure of these proteins to identify their roles.
Mutations in synaptotagmins in humans lead to severe neurodegenerative and neurological disorders like
Alzheimer’s. These studies will greatly advance our comprehension of NP sorting and illuminate the proteins and
pathways controlling their trafficking and release from neurons.

Public health relevance
Project Narrative Neuropeptides play a critical role in cell signaling, mediating development, physiology, and behavior. Abnormalities in the synthesis, trafficking or release of neuropeptides have been strongly linked with a wide range of neurological and neurodegenerative diseases and disorders like Alzheimer’s. Completion of these studies will elucidate potential mechanisms, pathways, and proteins that could be candidate targets for genetic and pharmacological treatments once their roles in governing neuropeptides in the nervous system are illuminated.